HEAL ERN: Data Coordinating Resource Center

Abstract
The NIH created the Helping to End Addiction Long-term (HEAL) initiative to speed scientic solutions to the
national opioid public health crisis. As part of the HEAL initiative, the HEAL Effectiveness Research Network
(ERN) was established to conduct comparative effectiveness trials for prevention and management of pain, while
reducing risk of addiction. Five ERN trials have been implemented with data coordination support from the
University of Utah Data Coordinating Resource Center. This proposal is written to provide continued support for
three of these trials that are expected to require no-cost extensions. As the Data Coordination Resource Center,
we will continue to work collaboratively with each ERN study team and the other HEAL ERN Resource Centers
to 1) develop, implement and monitor the ERN trials; 2) help respond to issues/protocol changes that emerge
during trial implementation and initiate timely necessary changes to assure trial success; 3) provide collection
and analysis of data; and 4) assist with timely publication of study results. Our supplement application has two
Specic Aims: Specifc Aim 1: Work with ERN investigators and other HEAL ERN Resource Centers to provide
collaborative clinical trial expertise and assistance in study and protocol design, single IRB, study implementation
and management, accrual of subjects, interim study reporting, nal study analyses, and assistance with timely
publication and dissemination of study results. Specific Aim 2: Provide comprehensive data management for
current and new ERN trials, including database and data collection systems, data management plans, data
risk assessment and quality control, implementation of randomization, assistance with Data Safety Monitoring
Board (DSMB) reports, and training for using the data collection systems. Additionally, we will facilitate sharing
of data from HEAL/ERN trials by incorporating HEAL Common Data Elements(CDEs) into protocols, continuing
to support NIH program staff in development of HEAL CDEs, continued participation in the HEAL Collective
Board, and preparation of nal data sets suitable for deposit in NIH-designated repositories for incorporation into
the HEAL Data Ecosystem. Our continued collaboration with ERN investigators and integration with the other
Resource Centers will maximize the likelihood of successful and timely completion of the HEAL ERN clinical
trials, leading to translation of research ndings to the effective management of acute and chronic pain, while
minimizing addictive opioid dosing regimens.

Public health relevance
Narrative The NIH created the Helping to End Addiction Long-term (HEAL) initiative to speed scientic solutions to the national opioid public health crisis. As part of the HEAL initiative, the HEAL Effectiveness Research Network (ERN) was established to conduct comparative effectiveness trials for prevention and management of pain, while reducing risk of addiction. The University of Utah will provide data coordination support for these trials, leading to more effective management of acute and chronic pain while reducing the risk of opioid addiction.